Practical Randomized Controlled Trial of Artificial Intelligence for Melanoma Diagnosis (PRACTA-MEL)

PROJECT SUMMARY/ABSTRACT
To reduce patient distress, combat rising healthcare costs, and improve overall patient outcomes, there is
pressing need to minimize number needed to biopsy (NNB) and maintain our melanoma detection rate. The
potential for curing melanoma through surgery alone, particularly at its earliest stages, underscores the
importance of early detection to reduce morbidity and mortality. However, the clinical diagnosis of melanoma is
challenging, resulting in dozens of unnecessary skin biopsies performed for every melanoma identified.
Algorithms have shown the potential to outperform and enhance the competence of expert dermatologists in
classifying dermoscopy photos by lesion diagnosis in controlled settings and pilot studies. Preliminary data from
single-center studies at Memorial Sloan Kettering Cancer Center (MSK) and Stanford University (SU) indicate
that utilization of artificial intelligence (AI) as a second opinion in lesions indicated for biopsy by the clinician can
improve the NNB; however, prior to implementing AI in clinical practice, deployment to the clinical setting must
be rigorously tested in order to assess and address potential risks of AI implicit biases. This proposal aims to
close this evidence gap and build real-world data through 2 specific aims: (1) determine the potential benefits
and barriers to technology adoption by performing a mixed qualitative and quantitative methods analysis of
clinician surveys, followed by implementation of a mitigation framework to overcome potential barriers; and (2)
determine the impact on NNB and melanoma detection rate with real time AI feedback by executing a dual center
phase 2 randomized controlled trial (RCT) at MSK and SU, which will be the first RCT of dermoscopy-based AI
in clinical practice. This trial will also maintain its focus on addressing potential AI biases by emphasizing diverse
recruitment, measuring how the trial team is doing both in performance and in recruitment, and oversight through
a steering committee of experts in AI bias with patient advocate engagement. The RCT will compare standard
of care dermatology visits for skin checks of lesions suspicious for melanoma (control arm) to visits that are the
same in every regard except for the addition of AI-assistance, representing an enhanced standard of care
(intervention arm). Through our partnership with Canfield Scientific, the AI algorithm on study will be seamlessly
integrated into clinics’ imaging process, enabling our research team to feasibly analyze a total of 18,000 lesions
on the RCT, giving our study significant power and generalizability. We will also make all images acquired in the
study public for future benchmarking. Our AI tool will be assessed for bias against Fitzpatrick Skin Type, which
will be metadata that is also made public to the International Skin Imaging Collaboration (ISIC) Archive for future
work. This project will lay the groundwork for the design and implementation of phase 3 multi-center clinical trials
to strengthen the evidence base for this cutting-edge technology in a move toward widespread clinical adoption.

Public health relevance
PROJECT NARRATIVE To combat rising healthcare costs and improve overall patient outcomes, there is pressing need to minimize number needed to biopsy (NNB) while continuing to find as many melanomas as possible; One promising solution is dermoscopic image-based artificial intelligence (AI) using convolutional neural networks, which can be seamlessly applied to images collected during routine clinical workflows in real-time. In order to address the current dearth of data and measure real-world impact to accelerate clinical adoption, this study proposes to: (1) determine the potential benefits and mitigate potential barriers to technology adoption by performing a mixed qualitative and quantitative investigation followed by implementation framework with clinicians; and (2) determine the impact on NNB and melanoma detection rate with real time AI feedback by executing a dual center randomized controlled trial (RCT), which will be the first RCT of dermoscopy-based AI in clinical practice. Throughout the study, potential biases of implemented algorithms will be of central concern to the investigators, measured on a regular basis throughout the trial, and overseen by a steering committee led by two experts in algorithmic bias and mitigation as well as community-based engagement with clinical research.